"Charting cellular attraction-based interactome with Multivalent Adhesive Probe AFM (MAPA)"

Adhesion of cells defined by physicochemical composition of the interacting cell surfaces is the key factor
determining organism development, tissue integrity, immune response, and cancer metastasis. Enormous
progress in this field achieved in recent years has been hampered by limited biophysical tools capable to
simultaneously measure adhesive properties of live cells, to qualitatively determine chemistry governing cell
bonding and to analyze distinct types of adhesion. Atomic force microscopy (AFM) based force spectrometry
can provide data on viscoelastic properties and limited receptor-targeted surface composition. Here we
propose to develop and validate technology that can deliver adhesion maps and physicochemical surface
composition maps of live cells. Our technology uniquely analyzes dispersive adhesion based on van der Waals
interactions not accessible by other methods, AFM based and beyond, focused on viscoelastic properties of
cells. Dispersive adhesion is especially relevant for invasive cells devoid of tumor microenvironment and
searching for interactions, such as circulating tumor cells (CTCs). We determined that properties of frequency
spectra of an AFM probe momentarily engaged in oscillation mode, based van der Waals interactions with an
object, strongly depend on physicochemistry of the tested material. In our pilot experiments we used frequency
spectra to fast and unambiguously identify distinct bio-relevant surfaces, cultured cancer cells of controlled
invasiveness, and cancer cells isolated from patients, which are mostly left unresolved with viscoelastic
adhesion. Therefore, we hypothesize that specific qualitative and quantitative data on dispersive cell adhesion
(no cell indentation, no elastic component) can be extracted from broad-range frequency spectra of an AFM
probe vibrating within the van der Waals distance above the cell surface. We plan to test our hypothesis and
develop the corresponding technology: Multivalent Adhesive Probe AFM (MAPA), in the following steps. (I)
First, we will determine technical benchmarks to measure adhesiveness of bio-relevant model surfaces. After
optimization of spectra collection, we will establish procedures for spectral analysis and derive biomaterial-
specific spectral signatures. (II) Next, we will extend the MAPA technology to test attractiveness of human
cultured prostate cancer cells subjected to invasion-promoting conditions: circulation-simulating fluid shear
stress, induction of epithelial to mesenchymal transition or fusion with tumor-associated macrophages to
produce aggressive tumor-macrophage hybrids (TMHs). (III) Finally, we will validate the MAPA technology with
CTCs and TMHs isolated from the blood of a small cohort of prostate cancer patients. We will aim at fast and
reliable discerning of fusion-prone CTCs and early-stage TMHs not detectible with AFM force spectrometry
and other single cell methods. The successful qualitative and quantitative interrogation of cell attractiveness
holds the promise not only to better understand the fundamental biological processes but also adds capability
to follow disease progression and response to therapies for improved diagnosis and prognosis.

Public health relevance
Changes in cell surface adhesion provide a sensitive indicator of cancer cell invasiveness. However, the parameter of cell attractiveness is underutilized in cancer cell biology due to the lack of robust methods offering both qualitative and quantitative measures. Here we propose to develop a Multivalent Adhesive Probe Atomic force microscopy based method (MAPA) for simultaneous quantitating the attraction of cancer cells and tissue samples and determining the physicochemical mechanism behind the surface adhesiveness.